Study of arenavirus assembly

The devastating impact on public health, global economy and social stability incurred by the COVID-19 pandemic
in the last two years has highlighted the importance of basic research into zoonotic pathogens. This application
describes structural and functional studies into the rodent-borne human pathogen lymphocytic choriomeningitis
virus (LCMV), a member of the Arenaviridae family in the Bunyavirales order. Like other members of the same
family, LCMV has a negative sense, bi-segmented genome consisting of a large (L) and a small (S) segment.
The L segment encodes the RNA-dependent RNA polymerase (L RdRp) protein and the multi-functional matrix
protein (Z). The S segment encodes the viral nucleoprotein (NP) and the glycoprotein (GP) precursor of the
glycoprotein complex (GPC) that is later cleaved into a stable signal peptide (SSP), GP1, and GP2. In the virion,
nucleocapsids of NP coated L and S segments associated with the L protein are copackaged through interactions
with membrane-associated Z proteins, which also interact with GPs embedded in the membrane envelope.
Although structures of individual proteins from AVs have been solved by x-ray crystallography or cryo electron
microscopy (cryoEM), the architectural organization of these proteins in the virion and the assembly mechanism
of NP and RNA into the nucleocapsid are poorly understood. We hypothesize that NP interacts with genomic
RNA segments and L RdRp to form a nucleocapsid, which is recruited to GP-decorated membrane patches
through Z for budding of virions. The proposed structural and functional studies aim to test this hypothesis of
LCMV virion and nucleocapsid assembly with techniques just established by our team in the collaborative studies
of vesicular stomatitis virus (VSV), another negative sense RNA virus. Specifically, cryo electron tomography
(cryoET) will be used to reconstruct the first 3D model of the LCMV virion at molecular resolution and atomic
models of individual proteins will be fitted into the virion tomogram to establish the architectural framework of the
virion and to unveil molecular interactions among GP, Z, NP and L proteins (Aim 1). Near-atomic resolution with
novel sub-particle reconstruction method will be used to image fully assembled nucleocapsids consisting of NP
protein and genomic RNA segment to define the protein-RNA interactions at atomic details. The nucleocapsid
structure will be used to guide sub-particle reconstruction workflow and be complemented by in situ structures
of nucleocapsids from virions (Aim 2). In both Aims, structure-guided functional studies will be performed to test
hypotheses of assembly mechanisms of LCMV nucleocapsid and virion. Structure-function relationship relevant
to viral RNA synthesis will also be explored. Overall, the anticipated results will provide new insights into the
mechanism of virion assembly and viral RNA synthesis, not only for LCMV but also for Arenaviruses in general.
The proposed studies harness cutting-edge technologies in structural biology and will generate new knowledge
of viral structures currently unavailable to any of Arenaviruses. As such, the innovative studies shall make unique
contributions by accelerating discoveries of antiviral agents and vaccines to control future AV outbreaks.

Public health relevance
The arenavirus family of the Bunyavirales order includes old world arenaviruses (such as Lassa fever virus and lymphocytic choriomeningitis virus) and new world viruses (such as Wachupo virus, Pichinde virus and Junin virus). These animal-borne viruses cause hemorrhagic fevers in humans and may result in a future pandemic. The proposed structural and functional studies of lymphocytic choriomeningitis virus facilitates development of vaccines and antiviral agents against arenaviruses.